Activation of the Ah receptor and epithelial integrity

Project Summary/Abstract
The human population is increasingly at risk of developing chronic diseases, such as obesity, atopic dermatitis
and inflammatory bowel disease, which together affects millions of people, thus representing a huge economic
burden. One of the major contributing factors to these diseases is epithelial barrier dysregulation. The Ah
receptor (AHR) is emerging as a major factor in the maintenance of immune surveillance and integrity of
barrier tissues (e.g. skin, intestinal tract). However, our knowledge of AHR function is often confusing and at
times appears contradictory. This proposal will pursue the innovative theory that the AHR is a central regulator
of host barrier homeostasis, and the localized response to commensal and pathogenic microbes upon tissue
damage leads to AHR activation and enhanced epithelial repair and barrier function. We have established an
innovative multi-disciplinary team of collaborators with the intention of providing a comprehensive
understanding of the physiological and toxicological routes of ligand stimulation, modes of activity and targets
of AHR activation within epithelial barriers (e.g. intestinal mucosa and skin). I have been studying the AHR
since 1984 and have made a number of unique and seminal contributions to our understanding of the
physiologic and toxicologic functions of the AHR, thus I believe I am well qualified to lead this effort.
Discoveries from the Perdew laboratory include complete characterization of the subunit composition of the
AHR complex, and the determination that the liganded AHR works with inflammatory transcription factors to
mediate cytokine/chemokine/growth factor signaling. We propose here to also examine the AHR as a potential
therapeutic target for a number of chronic diseases. However, excessive or sustained activation of the AHR
can lead to a variety of toxicities, so we plan to reconcile these opposing concepts. Humans are exposed to
complex mixtures of AHR ligands from the diet, through microbiota metabolism, endogenous metabolism, and
environmental contamination. Thus, there is a need to better understand the activities of this enigmatic
receptor, the influence of different classes of ligands, and the appropriate level of AHR activation required to
maintain health. Project 1 will identify and characterize proteins that interact with the AHR/selective AHR
modulator (SAhRM) complexes. Project 2 proposes to identify and assess the significance of dietary/bacterial
AHR ligands that are major sources of AHR activity. The identification of naturally occurring AHR ligands in the
diet or synthesized by microbes in the gut will provide insights concerning the homeostatic role of the AHR and
the risk of low-level exogenous ligand (e.g. TCDD) exposure. Project 3 will examine the ability of natural,
exogenous, and synthetic AHR ligands to modulate barrier function and immune signaling in intestinal models.
Project 4 will examine the ability of natural, exogenous, and synthetic AHR ligands to enhance barrier function
in skin models. This highly innovative proposal will explore and validate a model for AHR function that unifies
many diverse observations and will lead to important insights into the role of the AHR in disease processes.

Public health relevance
Project Narrative Numerous human diseases have as a major indication epithelial barrier dysregulation and the Ah receptor (AHR) has recently been shown to play an emerging role in the maintenance of epithelium and local immune status in barrier tissues, such as skin and the intestinal tract. We propose to identify and characterize the multiple sources of AHR ligands, determine the appropriate level of AHR ligand exposure that leads to optimal barrier tissue homeostasis and examine how low dose exposure to environmentally relevant potent AHR ligands may influence barrier tissue function. The possibility of using the AHR as a therapeutic target to enhance barrier tissue function will also be explored with a series of selective AHR modulators/agonist.